A “STICK” theranostic nanoplatform for image-guided drug delivery to brain malignancies

Title: A “STICK” theranostic nanoplatform for image-guided drug delivery to brain malignancies
Project Summary/Abstract
Our long-term goal is to engineer a new and generalizable drug delivery platform to improve the delivery of various
payloads to a series of brain malignancies and neurological disorders. The payloads can be imaging agents,
chemotherapeutics, molecularly targeted drugs and immunotherapeutics. We identified the following major barriers for
successful treatment of brain malignancies: 1) the blood-brain barrier/blood-brain tumor barrier (BBB/BBTB), 2)
severe destabilizing effect in blood circulation that leads to a poor central nervous system (CNS) pharmacokinetics
(PK) and 3) inability for agents to penetrate tumor tissue, and 4) lack of specificity for tumor cell delivery; resulting in
poor treatment efficacy and off-target toxicity. To this end, we propose an integrated approach to mitigate these
physiological barriers and mediate drug delivery to ensure disease targeting specificity. The goal of this revised
R01 renewal application is to develop a new Sequential Targeting In CrosslinKing (STICK) nano-delivery
platform to improve the drug delivery to brain malignancies. The characteristics of the proposed STICK
nanoparticle (STICK NP) allow it to overcome the multiple barriers to penetrate deeply in brain malignancies. In
Aim1, we will engineer new STICK NPs by designing new types of boronate crosslinkages to improve their
CNS PK to maximize the time window to enhance the glucose transporter (GLUT1)-mediated transcytosis
across the BBB/BBTB. The new crosslinkages also enhance the pH-responsive size transformation for
improved tumor tissue penetration and sialic acid-targeting selectivity for enhanced tumor cell specificity. Our
previous R01 grant focused on low grade brain tumors and as a logical but distinctive extension in this
research topic, the target of our current project is diffuse midline glioma (DMG, previously called Diffuse Intrinsic
Pontine Glioma (DIPG)), a high grade and the most aggressive form of pediatric glioma. DMG is the second
most common type of primary, high grade brain tumor occurring in children with a median survival <1 year from
diagnosis and the five-year survival rate of DMG is only around 2%. Discovery of the characteristic Histone 3-Lysine-
27-Methionine (H3K27M) mutation offers opportunity for development of targeted epigenetic therapies for this deadly
disease. In Aim2, we will quantitatively determine the spatiotemporal distribution of the newly engineered
STICK NPs in orthotopic DMG patient-derived xenograft (PDX) models and elucidate their delivery
mechanisms by optical imaging, magnetic resonance imaging, liquid chromatography-mass spectrometry (LC-
MS), and a series of biophysical approaches. In Aim3, two promising epigenetic drugs (panobinostat and
ONC201) will be specifically delivered to DMG by encapsulations within selected STICK NPs for epigenetic
therapy. The efficacy, toxicity, and molecular responses in tumor microenvironment will be investigated in
orthotopic PDX models and genetically engineered murine (GEM) DMG models. This project has the great
potential to significantly improve the clinical outcomes of DMG treatment. This concept can also be applied to
improve the treatment of many other brain malignancies such as glioblastoma and brain metastases.

Public health relevance
Project Narrative The successful development and translation of the proposed STICK nano-delivery platform will have a significant impact on the clinical management of diffuse midline glioma (DMG) as well as many other brain malignancies. This will be accomplished by minimizing drug release into normal tissues and limiting off-target toxicity, while maximizing tumor cell-specific drug delivery to DMG, thus dramatically enhancing therapeutic efficacy and minimizing off-target toxicity. The team of experts in pediatric neuro-oncology (Drs. Antony & Monje) and epigenetics in pediatric glioma (Dr. Knoepfler) will provide comprehensive expertise to facilitate the clinical development of the proposed novel targeting and transformable nano-theranostics that will ultimately benefit many patients with DMG.